Regulating Skeletal Connectivity in Craniofacial Development and Disease

PROJECT SUMMARY
The craniofacial skeleton is composed of multiple tissue types that must be precisely integrated during
development to ensure normal structure and function. While the mechanisms orchestrating this process are
key to revealing the etiology of congenital disorders with craniofacial differences, our current understanding of
the craniofacial skeleton is largely based on studies that focus on bone and cartilage. Conversely, the
mechanisms that regulate differentiation and patterning of diverse soft connective tissues, inter-tissue
crosstalk, and the formation of the connections between different tissue types in the head remain largely
unknown. The scope of the proposed study is comprehensive and forward-thinking, as it investigates the
craniofacial skeleton as a multi-tissue system, addressing critical gaps in our understanding of craniofacial
connective tissue development and maintenance in four complementary research programs. These programs
leverage Dr. Amy Merrill’s expertise craniofacial development to decode the molecular identities of connective
tissue cells, reveal their role in joint development and maintenance, identify the signals that bridge connective
tissue and bone, and establish novel associations between connective tissue development and human
disease. Utilizing both disease-first and gene-first approaches from this distinct perspective, alongside an
expert team of human geneticists, this research aims to identify new genes variants that cause human
craniofacial disorders. Cutting-edge techniques in spatial transcriptomics and mouse genetics will be used to
identify genes and pathways regulating assembly of the craniofacial skeleton, engineer new tools that target
and track understudied skeletal tissue types, and establish powerful models of human congenital disorders.
The increased flexibility and duration of the R35 grant will facilitate these technological advances, breaking
new ground to uncover fundamental programs that regulate skeletal connectivity in craniofacial development
and disease. Dr. Merrill is uniquely poised to successfully lead this study at the University of Southern
California in the Center for Craniofacial Molecular Biology, a rapidly growing research center with exceptional
resources directed by Dr. Yang Chai. She has an outstanding record of research productivity and impact in the
field of craniofacial biology and currently holds two R01’s from NIDCR. Dr. Merrill has shown excellence in
mentoring, which is reflected by the success of her trainees, recognition with the prestigious USC Mentoring
Award in 2022, and role as Co-Investigator on USC’s NIDCR T90 Training Grant for Craniofacial Biology. She
has also shown sustained commitment to professional service within the research community, serving in
various leadership roles, including President-elect of the Society of Craniofacial Genetics and Developmental
Biology. Dr. Merrill’s contributions to research, mentoring, and service position her on an upward trajectory to
advance our understanding of craniofacial development, ultimately paving the way for diagnosis and treatment
of congenital craniofacial disorders.

Public health relevance
PROJECT NARRATIVE The craniofacial skeleton is composed of diverse tissue types and their precise integration during development is necessary for normal structure and function. We propose to use mouse and human genetics to reveal the mechanisms that coordinate development, assembly, and maintenance of the craniofacial skeleton as multi-tissue system. Our overall goal is to reveal new insights into the etiology of congenital craniofacial disorders and harness this knowledge for therapeutic innovations.